Core Grant for Vision Research

Project Summary (Overall)
Continuing funds are requested by 18 vision scientists (holding 20 eligible NEI R01 grants) and their
personnel to support three resource and an administrative core in the merged Department of Ophthalmology,
Visual and Anatomical Sciences (former Ophthalmology and Anatomy/Cell Biology Departments). The
Administrative core will support the overall management of the Core. The research cores will enable and
enhance vision research at Wayne State University and for two members at nearby (15 minutes) Oakland
University. Facilities requested are: lmaging/Histopathology (I/H), Immunology (I) and Tissue
Culture/Molecular (TC/M). The I/H core in Scott Hall will provide for confocal laser scanning, light microscopy,
immunofluorescence, OCT and other cell imaging analyses (e.g., cell viability and quantification of plasma
membrane potential), and train in equipment use. There also is assistance/training in management of digital
images, slit lamp photography, and poster and publication production. The I core, at Kresge Eye Institute, will
provide immunological assays and consultation to these vision researchers. It will initiate and stimulate
innovative research projects that address emerging questions on the immunological basis of many ocular
diseases. Among its functions, it will provide for isolation of peripheral blood cells for staining or viable
cryopreservation, immunophenotyping, phagocytosis assays, ELISA and Western blot evaluation of
cytokines/chemokines and other molecules from tissue lysates and culture supernates, image analysis for
Western blots, data management and storage, and access to the Flow cytometers (Acuri 6 and Cytek
Northern LIghts), and Cellometer instruments and to the Karmanos Flow facility. The TC/M facility, located in
Scott Hall, will assist and train for preparation of specialized media, isolation, purification and characterization
of ocular cells for primary culture, subculture and propagation of established cell lines, adherence assays,
biofilm evaluation using crystal violet staining, genotyping of mice, cryopreservation of cells, and advice on
AAV vector design, DNA cloning, site directed mutagenesis, and DNA transfection. Assistance and training is
also available for techniques in molecular biology including PCR array and real time RT-PCR, CRISPR/cas9,
storage of bacteria (including multi-drug resistant isolates), vectors and cDNA constructs. Each of the cores is
staffed by well-trained research assistants and directors are NEI-R01 supported. The core directors and PI,
as a team, prioritize NEl R01 supported studies, promote collaboration, and assist in gathering preliminary
data for new NEI R01 submissions.

Public health relevance
Project Narrative Continuing funds are requested by 18 vision scientists (holding 20 core eligible NEI R01 grants) to support three resource cores in the merged Department of Ophthalmology, Visual and Anatomical Sciences (official partnering of Ophthalmology and Anatomy/Cell Biology Departments). The cores requested will be central facilities that offer state of the art equipment and experienced research assistants with a common purpose to enable and enhance R01 funded vision research at Wayne State University, and the nearby institution, Oakland University (15 minutes away).